Impact of Sugary Beverage Taxes on Weight and Health Outcomes after 3-5 Years

PROJECT SUMMARY
Despite widespread publicity of the obesity epidemic in the US and other developed countries, its prevalence
remains unabated. With almost 20% of children and adolescents and 40% of adults in the US with obesity, we
face a public health crisis. Blacks, Hispanics, and people with low socioeconomic status are disproportionately
affected. Multi-level and multi-pronged approaches are needed to stem this epidemic. One recommended
approach is population-based strategies that make it easier for people to make more healthful choices. One
such strategy is imposing taxes to reduce consumption of sugar-sweetened beverages (SSB). Not only are
SSB the largest contributor of added sugar in the US diet and have been tied to obesity and its comorbidities,
but national survey data suggest that ½ of adults and 2/3 of youth consume at least one SSB on a given day. If
taxes can reduce SSB consumption, it follows that obesity prevalence will fall, along with obesity-related
diseases. In Berkeley, CA (the first city to levy a SSB tax [in 2015]) SSB sales declined 9.6% and SSB
consumption declined 19.8% in the first year after tax implementation. There are indications that effects were
greater in low-income neighborhoods. We propose to evaluate the natural experiment of SSB taxes on weight
change in youth and adults and to explore possible effects on glycated hemoglobin (HbA1c) levels and
diabetes incidence among a cohort of adults with prediabetes. Oakland, Albany, and San Francisco have also
levied an excise tax on SSB – cities in which a large number of residents are patients (approximately 230,000
adults and 50,000 youth) of Kaiser Permanente Northern California (KPNC). Using our electronic medical
records (EMR), we will examine body mass index (BMI; kg/m2) trajectories, HbA1c levels, and incidence of
diabetes prior and after initiation of SSB taxes, using two different analyses (synthetic controls and differences
in differences) to optimize the rigor of our results. KP patients living in Northern California and Southern
California cities comparable to cities with a SSB tax will be used as controls. We hypothesize that cities with a
SSB tax will experience favorable changes in BMI, HbA1c, and diabetes incidence compared with comparison
cities. Our specific aims are to 1) Examine differences in BMI trajectories and prevalence of overweight and
obesity before and after implementation of a SSB tax among youth and adults separately in California cities
with and without a SSB tax. 2) Assess how youth and adult characteristics, such as age, race/ethnicity, BMI
category, and neighborhood socioeconomic status, may modify the impact of SSB taxes on BMI and
prevalence of overweight and obesity. 3) Explore differences in mean HbA1c levels and diabetes incidence
among an age/sex/race/BMI and neighborhood socioeconomic status matched cohort of adults with
prediabetes who live and do not live in SSB tax cities. This information is needed to guide health advocates
and policy makers with respect to the role of SSB taxes in obesity prevention.

Public health relevance
PROJECT NARRATIVE Obesity prevalence is a public health concern that needs multiple interventions at multiple levels to conquer. One strategy is the policy of implementing excise taxes on sugar-sweetened beverages (SSBs). We will examine the effects of city-level SSB taxes on body mass index and diabetes incidence among prediabetics. This study will be the first to examine health outcomes and include control cities without similar taxes.